Targeting Polyamine Metabolism in Relapsed Acute Myeloid Leukemia Stem Cells

Project Summary
The overall goal of this project is to target and mechanistically interrogate polyamine metabolism in leukemia
stem cells (LSCs) with the long-term objective of developing LSC directed therapy to improve the outcomes of
patients with acute myeloid leukemia (AML). AML is a devasting disease with a 30% five-year survival rate, in
part due to high relapse rates. While most AML patients achieve a clinical response, therapy resistant AML cells
often persist post treatment. A subset of therapy resistant cells called leukemia stem cells (LSCs) exist in residual
disease and are responsible for driving disease relapse in most AML patients; making it is critically important to
develop new therapies to target the LSC population to improve AML patient outcomes. LSCs have unique and
targetable metabolic requirements. Using mass spectrometry-based metabolomics analysis, we have shown that
the metabolite levels within LSCs isolated from primary AML patients are distinct from their normal counterpart,
hematopoietic stem and progenitor cells (HSPCs). Polyamine levels were significantly increased in LSCs
compared HSPCs. Pharmacologic depletion of polyamine levels showed that LSCs are reliant on polyamine
metabolism for their survival. Polyamines are cationic compounds containing at least two amino groups, that
have pleiotropic effects on cell function and importantly have not been examined in LSC biology. Mechanistic
interrogation of polyamine biology in LSCs revealed that polyamines are used to regulate protein synthesis.
Polyamines regulate mRNA translation by serving as a precursor for the post-translational modification,
hypusination, which is essential for the activity of the eukaryotic initiation factor 5A (eIF5A). eIF5A is a translation
elongation factor that is important in the synthesis of a subset of proteins that contain amino acid sequences that
are less efficient at forming peptide bonds such as proline rich regions. Thus, polyamines may mediate LSC
function through the regulation of protein synthesis of select mRNAs that are essential for LSC survival. Based
on our preliminary data, we hypothesize that polyamines are required for LSC function through their role in
regulating eIF5A-dependent protein synthesis. We will examine this hypothesis by determining the molecular
and biological consequences of polyamine depletion in LSCs. (Aim 1). Further, mechanistically dissect the role
of polyamines in regulating eIF5A dependent protein synthesis in LSC function (Aim 2). Through these highly
translational studies, we expect to determine the importance of polyamine supported eIF5A hypusination on LSC
function and evaluate the therapeutic potential of targeting polyamine metabolism in AML. Our studies will reveal
novel LSC biology, the mechanisms by which polyamine depletion/reduced eIF5A hypusination decrease LSC
function and define potential pathways the mediate resistance to polyamine depletion in LSCs. We anticipate
the proposed experiments will serve as the foundation for a future clinical trial targeting polyamine metabolism
in AML.

Public health relevance
Project Narrative Acute myeloid leukemia (AML) is a devasting blood cancer with particularly poor outcomes. Outcomes for AML patients have remained poor, due to our inability to fully eradicate a population of therapy resistant cells called leukemia stem cells (LSC). In this proposal, we will use advanced pre-clinical models to examine a newly discovered vulnerability of LSCs, polyamine metabolism, with the overall goal of developing new strategies to better target LSCs and improve AML patient outcomes.